Assessing Time-to-Treatment Variability in Antiretroviral Penetration by Multimodal Imaging

ABSTRACT
HIV remains persistently detectable within tissues during antiretroviral treatment (ART) and can rebound
throughout the body following a treatment interruption. Low concentrations of antiretrovirals (ARVs) may be
present within these tissue viral reservoirs, such as lymph nodes, which may provide localized sanctuaries for
virus. Understanding the potential role of pharmacology in the persistence of virus during treatment and
subsequent viral reactivation following treatment interruption is critical for targeting strategies to achieve a
functional cure. This remains a knowledge gap because of existing limitations in measuring tissue ARV
concentrations by standard LC-MS/MS methods. These methods cannot capture variability in drug penetration
within the tissue microenvironment that may limit exposure to cells targeted by virus. We have developed a new
approach for quantifying ARVs in tissues based on IR-MALDESI MSI, which offers the ability to map spatial
distributions of drugs. Using this approach we have demonstrated heterogeneous ARV distributions, often
detected as monotherapy, across a range of putative reservoir tissues. We hypothesize that progressive HIV
pathogenesis can induce structural and morphological modifications in tissue (e.g. fibrosis) that may limit
penetration of ART to some T cell populations within reservoir tissues. To investigate this question, we will
combine multiple cutting-edge imaging techniques to simultaneously characterize and quantify distributions of
drug, virus, and host response within tissues of a rhesus macaque (RM) animal model using a well-characterized
SIV strain that provides a robust, predictable pathogenic response. With long-acting injections (LAI) emerging
as an alternative to daily therapy, this effort will investigate differences in ARV tissue penetration through each
of these two routes of administration. Three specific aims are proposed: 1) Characterize tissue PK using IR-
MALDESI MSI in reservoir tissues following treatment initiation in acute or late chronic infection. 2) Use a novel
multimodal spatial imaging suite (IR-MALDESI MSI, RNAscope in situ hybridization, spatial transcriptomics) to
evaluate differences in tissue PK/PD based on timing of treatment initiation. 3) Identify lipidomic/metabolomic
markers of immune responses in tissue by IR-MALDESI MSI and develop an innovative single-assay approach
to tissue PK/PD assessment. When completed, this proposal will benchmark PK of long-acting and daily
treatment combinations for the first time in healthy RM and assess how the extent of immunopathogenic damage
prior to treatment initiation influences ARV tissue penetration. These data will provide insight into how delivery
of new therapies LAI strategies can optimize clinical outcomes

Public health relevance
PROJECT NARRATIVE Even though HIV infection can be controlled through antiretroviral therapy, HIV remains present throughout the body and rebounds quickly once treatment is interrupted. This rebound may occur in part because not enough drug is able to reach HIV in some tissues, but existing methods to measure antiretrovirals can’t provide information about where drugs go within tissues and whether that matches up with where SIV+ (and by extension HIV+) cells are localized. This project will study whether changes to tissue structure taking place in response to SIV before treatment begins restricts antiretrovirals from effectively reaching SIV-infected cells using a combination of new imaging techniques.